Research Training in Infectious Diseases

The objective of this program is to train physician-scientists in basic, translational, and clinical
biomedical research focusing on infectious diseases. The training program will use the
resources of 3 allied institutions, co-located on the east side of Manhattan: Weill Cornell
Medicine as the primary institutions, with collaborators at The Rockefeller University and Sloan-
Kettering Cancer Institute. The program's faculty are well-funded scientists with independent
research support who are committed to research and training. They are complemented by 3
international collaborators from Brazil and Haiti. The faculty share the view that the physician-
scientist truly is an endangered species and are committed to address this issue by establishing
long-term mentoring relationships with postdoctoral trainees.
The broad areas of research training are: immunology, malaria, mycobacteriology, virology, and
translational/clinical research, including bacteria, fungi, HIV/AIDS and other infectious diseases
of global importance. Trainees and mentors will develop an individual development plan (IDP)
that can include, for example, additional formal courses in the Weill Cornell Graduate School
(e.g. immunology, molecular biology) or enrollment in a K30 Master in Clinical Investigation
program.
During the funding period (1999-2019), 48 trainees were appointed and 48 (100%) completed
their training (5 continue in the program). Twenty-three (53%) of 43 who completed the program
received NIH K Awards and one other is reapplying for a K23. Research subject areas included:
drug-resistant bacteria, HCV, HIV, KSV-HHV8, malaria, schistosomiasis, and tuberculosis. A
total of 74% hold current appointments at academic institutions and over 75% currently conduct
research. In total, 23 (48%) of all T32 trainees were women, 8 (17%) were racial/ethnic
minorities, and 2 (4%) were from disadvantaged backgrounds.
The program will continue to recruit physicians who have completed their clinical training
(medicine, pediatrics, pathology) and are seeking academic investigative careers. This training
grant will provide developing physician-scientists with the opportunity to make the transition
from clinical training to basic, translational, or clinical research.

Public health relevance
This training program will provide physician-scientists with the mentoring and skills needed to embark on successful careers conducting research in infectious diseases of public health importance in the Unites States and worldwide. The training will focus on HIV, malaria, drug- resistant bacteria, tuberculosis and other diseases of global importance.